Biochemistry Core

1. Core utilization and accomplishments
- Consultations for demanding assay methods, and instrument operation training with data analysis: a total of 1,642 hours of consultations on new or ongoing projects by 37 laboratories, NHLBI, 30; non-NHLBI, 7
- Developing and implementing LC/MS methods for 1) mass measurement of intact proteins and organic compounds: a total of 3,088 quantities from 25 laboratories
- Separation and quantitation of proteins or metabolites by HPLC: a total of 1,286 quantities from 5 laboratories.

2. Core publications
- Butt, H., et al., Comparative Analysis of CRISPR-Cas9, Lentiviral Transduction, and Base Editing for Sickle Cell Disease Therapy in a Murine Model. Transplantation and Cellular Therapy (2025) 31, S1-S2
- Wu, J., et al., Mitochondrial fatty acid oxidation regulates monocytic type1 interferon signaling via histone acetylation. Sci. Adv. (2025) 11, eqdq9301
- Chen, J., et al., Tubulin code eraser CCP5 binds branch glutamates by substrate deformation. Nature (2024) 631, 905-912
- Jiang, C., et al., Systemic Identification of Functionally Conserved Long Noncoding RNA Metabolic Regulators in Human and Mouse Livers. Gastroenterology (2025) In press

3. New instrumentation and new services
- Developed the new LC/MS methods for the specific metabolites and drug compounds (R406-Syk inhibitor, Ivosidenib derivatives – anti-cancer medication, a complex of Prazole derivatives and target peptides using Native MS spectrometry, succinate/lactate, etc.).

4. FY24 budget
The budget was spent 99% as of August 11, 2025
- Maintenance contract for LC/MS---- 57%
- Repair part for the LC/MS -------- 10%
- General consumables and solvents---33%